Niche-specific endothelial mechanisms regulating the extravasation of hematopoietic stem cells

PROJECT SUMMARY
Hematopoietic stem cell (HSC) transplantation is a potentially curative treatment for numerous blood and
immune disorders. The process itself, however, is inefficient and can leave patients immunocompromised and
vulnerable to life-threatening infections for up to a year post-transplantation. Only once donor HSCs engraft in
the recipient’s bone marrow niches can the stem cells regenerate a new immune system. In this proposal, we
aim to elucidate the key endothelial mechanisms that direct circulating HSCs across the blood vessel wall and
into their niche. Our studies will pave the way for the development of novel therapeutics to accelerate post-
transplant immune recovery by enhancing the niche migration of HSCs. In mammals, the trans-endothelial
migration of HSCs occurs deep inside opaque bones, which are largely inaccessible to imaging and
experimentation in live animals. The transparent zebrafish embryo, by contrast, which has a blood and
vascular system highly similar to that of humans, enables direct visualization of HSC migration with
unprecedented sub-cellular resolution. We previously identified a conserved gene expression signature for
HSC niche endothelial cells, which includes molecules with cell adhesion and endocytosis/vesicle trafficking
functions. Consistent with this, intravenous injection of fluorescent endocytosis reporters revealed a high level
of endocytosis activity, with each niche endothelial cell harboring a discrete cluster of endocytic activity. Using
high-resolution time-lapse microscopy, we observed adherent HSCs initiating trans-endothelial migration into
the niche specifically through these endocytic clusters. In preliminary studies, we disrupted candidate factors
from our niche endothelial signature, which blocked endocytosis in the niche endothelium and impaired HSC
migration. Together, our data suggest that a combination of specific cell adhesion and endocytosis/vesicle
trafficking machinery within the endothelium facilitate the extravasation of HSCs into their niche, a hypothesis
we will test in our proposed aims. In Aim 1, we employ high-resolution live cell imaging in combination with
structure-function studies and in vivo proximity-dependent biotinylation in zebrafish, to define the endothelial
receptor domains and binding partners that mediate the adhesion and trans-endothelial migration of HSCs. In
Aim 2, we use loss-of-function chemical and genetic tools in combination with overexpression studies, both in
the zebrafish and a biomimetic human blood vessel model, to determine the conserved vascular endocytosis
and membrane trafficking machinery that is necessary and sufficient to trigger HSC extravasation. Together,
our studies will provide novel molecular targets for the design of new endothelial-focused therapeutics aimed at
more efficiently guiding HSCs into the bone marrow, which could accelerate immune system recovery following
HSC transplantation.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell (HSC) transplantation can be a lifesaving treatment for numerous blood and immune disorders including cancer, yet it remains a risky procedure, often leaving patients immunocompromised and vulnerable to infection for several months post-transplant. A better understanding of the mechanisms that guide donor HSCs out of circulation and into the recipient’s bone marrow, which must happen before the stem cells can regenerate a new immune system, could aid the development of novel therapeutics to accelerate stem cell migration and immune system recovery. Our proposed studies will fulfill this critical unmet need by defining the cellular biology and molecular pathways within specialized cells of the vasculature that facilitate HSC migration into the bone marrow.